The Role of Neighborhood Greenspace in reducing Risk of Hypertensive Disorders of Pregnancy, Chronic Hypertension, and Racial Disparities in Maternal Morbidity

PROJECT SUMMARY
Hypertensive disorders of pregnancy (HDP) are a leading cause of maternal mortality and morbidity in the US,
particularly for Black patients who are at greatest risk of poor outcomes. In addition to contributions to maternal
mortality, HDP increase the risk of chronic hypertension (cHTN), which can lead to cardiovascular (CV)
disease. Our parent grant (R01HL157160) is focused on neighborhood greenspace and its impact on HDP and
subsequent cHTN using observational and experimental methods. The objective of this supplement
proposal is to add crucial variables relevant to climate change and health (CCH) to this project. We will
bring Dr. Allan Just onto our team to add temperature and air pollution, specifically particulate matter
<2.5µm in diameter (PM2.5) to GeoBirth which is the cohort on which our parent project is based.
GeoBirth includes 116,000 pregnant patients who gave birth in two Philadelphia hospitals from 2008 to
present. We will analyze the 89,827 Philadelphia residents who gave birth from 2008-2020. Our overarching
hypothesis is that extreme heat and elevated PM2.5 exposure contribute to the risks of, and racial disparities
in, HDP and cHTN after pregnancy. We propose the following aims: 1) Observational: Quantify associations
of extreme heat with HDP and cHTN after pregnancy and determine the extent to which heat mediates
racial disparities in these outcomes. We will analyze associations of extreme heat with risk of HDP using
multilevel logistic regression adjusted for individual and neighborhood-level confounders (1a). We will
determine if extreme heat exposure is associated with risk of cHTN within 5 years after pregnancy using
survival analysis methods (1b). We will quantify the extent to which extreme heat exposure among Black
patients contributes to Black-White HDP and cHTN disparities using causal mediation and interaction analyses
(1c). 2) Observational: Quantify associations of PM2.5 with HDP and cHTN after pregnancy and
determine the extent to which PM2.5 mediates racial disparities in these outcomes. We will perform
analogous analyses to Aim 1, using trimester-specific PM2.5 exposure in lieu of temperature. 3) Experimental:
Determine the extent to which vacant lot greening mitigates exposure to extreme heat. We will also use
data from a completed cluster RCT (2011-2014) to examine the impact of greening on ambient temperature in
neighborhoods with clusters of 541 vacant lots in three trial conditions: greened; trash clean-up only; and
control. This study will advance the field of women's CVD research by addressing the impact of climate
change-related exposures to HDP and cHTN that lead to disproportionately high rates of mortality among
Black patients. Our findings will inform individual-level clinical prevention efforts of CVD through personal
exposure reduction in addition to large-scale urban policy changes to mitigate heat and pollution exposures.

Public health relevance
PROJECT NARRATIVE The objective of this Administrative Supplement proposal is to add crucial variables relevant to climate change and health to GeoBirth, a cohort of 89,827 Philadelphia residents who gave birth from 2008 to 2020 who serve as the study population for the Parent R01 (R01HL157160). The Parent R01 is focused on greenspace and hypertensive disorders of pregnancy (HDP) and chronic hypertension (cHTN) after pregnancy. We will bring a climate and health scientist onto our team to add fine-scale exposure estimates for temperature and air pollution, specifically PM2.5, to test our hypothesis that extreme heat and elevated PM2.5 exposure contribute to the risks of, and racial disparities in, HDP and cHTN after pregnancy.